Columbia Population Research Center - Administrative Core

Administrative Core – Abstract
The administrative core (AC), led by center co-directors Jennifer S. Hirsch and Jane Waldfogel, oversees,
coordinates, and supports all of CPRC’s activities, including those provided through the development core, the
computing and methods core, the five primary research areas (PRAs), the cross-cutting theme, and the
working groups. The AC’s specific aims are to: 1) manage and coordinate all of the center’s activities, including
the new partnership with the City University of New York (CUNY); 2) provide ongoing fiscal, strategic, and
substantive oversight to the center; 3) ensure priority access to core services for junior scientists, including a
new targeted program of pre- and post-award support, and 4) facilitate communication within CPRC, between
CPRC and the broader university, between CPRC and CUNY, and with the Association of Population Centers
and the P2C coordinating center. By ensuring that all CPRC components function smoothly, providing
administrative support for the computing and methods core and the development core, and ensuring that core
and center-wide metrics are consistently collected and reviewed, the administrative core anchors CPRC’s work
to maximize the efficiency and impact of population dynamics research at Columbia and to promote the
independence and success of junior scientists.